PS24-063, MARI Project: SALUD MOVIL: Strengthening Access in Latinos Using Digital and Mobile Outreach through Versatile, Inclusive, and Latino-centered Healthcare Innovations

PROJECT SUMMARY / ABSTRACT
Racial and ethnic minorities are overrepresented in the HIV Epidemic, particularly in the Southern United States.
Over the past decade, Hispanic and Latino Gay and Bisexual Men (HLGBM) in Georgia have experienced a
21% increase in new HIV infections, starkly contrasted with the 4% and 1% increases among Black and White
counterparts, respectively. Furthermore, at least five HIV molecular clusters have been identified in Georgia in
recent years, primarily affecting HLGBM. Our previous collaborations with the Centers for Disease Control and
Prevention, state and local health departments, and community organizations revealed important barriers faced
by HLGBM in accessing sexual health services. These include scarcity of bilingual healthcare providers, distrust
in healthcare and governmental institutions, segregation, transportation barriers, among other important social
and structural barriers.
In response, our team secured federal funding and, in May 2023, launched a community-guided social media
campaign promoting a citywide bilingual peer-navigator program. This initiative focuses on connecting HLGBM
to accessible, affordable sexual health services across Atlanta. The program was well-received and ultimately
adopted by local health districts and users praised the program’s patient-centered approach. Nevertheless,
challenges such as extended wait times for appointments, scheduling conflicts, limited operating hours,
transportation challenges, and limited bilingual HIV care providers at all levels persist.
Our proposed project, “SALUD MOVIL”, builds on the success of the peer-navigator program, employing
technology, convenient laboratory testing, and robust community-informed and implementation-science
frameworks to tackle the social and structural barriers hindering care delivery among HLGBM. “SALUD MOVIL”
addresses the four pillars of the Ending the HIV Epidemic (EHE), and is aimed to RESPOND to the increases in
new HIV diagnoses and clusters in HLGBM, by applying Community-Based Participatory Research Principles
and Implementation Science Frameworks to inform the adaptation and integration (Aim 1) of a bundle of two
evidence-based interventions (EBIs): 1) Bilingual telemedicine for HIV TREATMENT and PREVENTION,
coupled with 2) Mobile HIV/STI TESTING and phlebotomy services. These adapted EBIs will then be piloted,
and implementation outcomes measured. Our goal is to develop a toolkit for broader translation, providing
guidance to scale the program and address HLGBM's social and structural challenges in other settings.

Public health relevance
PROJECT NARRATIVE Over the past decade, Hispanic and Latino Gay and Bisexual (HLGBM) men in Georgia have experienced a surge in HIV diagnoses, leading to the creation of a bilingual peer navigator program in Atlanta to tackle the unique access barriers to sexual health services among HLGBM. Despite the program’s popularity, HLGBM still face challenges in accessing services like long wait times, transportation issues, and a lack of Spanish-speaking providers. To address these issues, we're propose "SALUD MOVIL," a project combining bilingual telemedicine and mobile HIV/STI testing to enhance healthcare accessibility among HLGBM.